The Unexpected Role of TNFRSF14 Signaling in Promoting Antibody-Dependent Cell-Mediated Cytotoxicity

Vaccine development has been dominated by efforts to elicit neutralizing responses, but this approach
has met with limited success for several major pathogens including herpes simplex virus (HSV). We
adopted a paradigm-shifting strategy and engineered a single-cycle HSV strain deleted in viral
glycoprotein D, designated ∆gD-2. Glycoprotein D, which is required for viral entry and spread, was the
primary target of neutralizing antibody responses elicited by the prior failed vaccine efforts. Immunization
with this novel ∆gD-2 vaccine strain completely protected mice from lethal challenges with clinical isolates
of HSV-1 and HSV-2. Passive transfer studies demonstrated that the protection was mediated by
antibodies that had little neutralizing activity but instead mediated antibody-dependent cellular cytotoxicity
(ADCC). Monoclonal antibodies from the vaccinated mice were subsequently isolated and characterized.
The most potent of these, BMPC-23, had no neutralizing activity but activated mouse FcγRIV, a biomarker
of ADCC. A single dose of BMPC-23 administered 24 hours before or after viral challenge provided
significant protection when configured as mouse IgG2c and protected mice expressing human FcγRIII
when engineered as a human IgG1. Using cryo-electron microscopy, we demonstrated that the epitope
recognized by this protective monoclonal antibody resides within domain IV of glycoprotein B. HSV can
escape neutralization by spreading across intercellular bridges but cannot escape ADCC. Glycoprotein
D binds TNFRSF14, an immunomodulatory protein that functions in signal transduction, and completes
with its physiological ligands, resulting in altered signaling. Thus, we hypothesized that HSV utilizes gD-
TNFRSF14 engagement as an immune evasion strategy to block ADCC responses. Consistent with this
hypothesis, we found that BMPC-23 failed to protect TNFRSF14 knockout mice and similarly, passive
transfer of immune serum pooled from ∆gD-2 vaccinated mice (replete with ADCC-mediating activity)
protected wild-type but not the knockout mice. The importance of TNFRSF14 in mediating ADCC is
generalizable as we obtained similar results using human TNFRSF14 knockout effector cells in ADCC
assays with other antigen-antibody complexes such as those formed by rituximab with B cell-presented
CD20. The identification of a central role for TNFRSF14 in promoting ADCC provides a unique
opportunity to define the signaling pathways and biochemical and structural determinants that mediate
ADCC. We will take advantage of human knockout cells, a library of defined TNFRSF14 muteins,
structural characterization and monoclonal antibodies that target glycoprotein B but exhibit variable
ADCC activity to identify the pathways and the monoclonal antibody characteristics that promote FcγR
activation. The results of these studies will provide an enhanced foundation and new strategies for future
vaccine and monoclonal antibody design.

Public health relevance
Clinical experiences and failed vaccine trials highlight the central role of antibody-dependent cell- mediated cytotoxicity (ADCC) in protection against herpes simplex virus (HSV) infections but HSV blocks ADCC responses by disrupting interactions between an immunomodulatory signaling protein, TNFRSF14, and its natural ligands. TNFRSF14 signaling is required for Fcγ receptor activation and ADCC against a broad range of targets. The goal of this proposal is to determine how TNFRSF14 activates the Fcγ receptor signaling cascade that culminates in ADCC, which will provide the framework for future vaccine and monoclonal antibody development.